The interplay between HIV-1 and amyloid precursor protein in infection and neurotoxicity

PROJECT SUMMARY
Human Immunodeficiency Virus type 1 (HIV-1) infects a number of different immune cell types with diverse
replication strategies and clinical outcomes. Amongst these, we have a good understanding of infection in T-
Cells, depletion of which results in Acquired Immune Deficiency Syndrome (AIDS). Moreover, AIDS is now well
controlled using combination anti-retroviral therapy (cART), meaning the duration and quality of life has greatly
increased for many people living with HIV-1. However, an estimated 50% of HIV-1 patients in the US still
develop HIV-1-asssociated dementia (HAND) and other neurocognitive disorders. This is because beyond T-
Cells, HIV-1 also enters the central nervous system (CNS) and establishes a reservoir of infection in brain-
resident macrophages and microglia that is more difficult to treat. In addition, virus replication strategies in
macrophage and microglia differ from those in T-Cells, particularly at late stages, and remain less well
understood. What is clear is that HIV-1 replication in these cells results in secretion of a complex mixture of
host cytokines and other toxic products, as well as viral proteins, each contributing to a neurotoxic environment
that remains intensely studied yet challenging to treat. Understanding how HIV-1 replicates in brain-resident
immune cells and the host factors involved is therefore of high significance and has the potential to guide
future drug design. Our prior work and new preliminary data reveal that Amyloid Precursor Protein (APP) is
highly expressed in macrophages and microglia and plays a pivotal role in both regulating HIV-1 infection and
production of neurotoxic compounds by infected cells. APP is a transmembrane protein that is processed
through a non-amyloidogenic (non-toxic) pathway at the plasma membrane or an amyloidogenic pathway
within endolysosomes and multivesicular bodies (MVBs), which produces amyloid proteins that aggregate and
form plaques associated with neurodegenerative conditions such as Alzheimer’s Disease as well as HAND.
Our data shows that amyloidogenic APP processing and associated formation of a cleavage product termed
C99 functions to restrict HIV-1 replication in macrophages and microglia as well as a number of cell line
models. Specifically, C99 competes with the HIV-1 Gag polyprotein for access to and control of MVB sorting,
suppressing the production and release of new infectious virions. Understanding how APP and C99 function in
more detail will therefore provide important new insights into macrophage/microglia-specific HIV-1 replication
strategies and restrictions. To evade APP activity, Gag competes to direct MVBs to exocytic pathways that
enable virus release but also enhance APP processing and secretion of amyloids. As such, the battle between
APP and Gag determines the overall level of virus replication and amyloid production in infected cells, which
we will explore in Aim 1. Our data also shows that novel compounds termed γ-secretase modulators (GSM’s)
can be used to tilt this battle in favor of the cell by preventing APP processing to simultaneously harness its
activity to inhibit HIV-1 replication and to suppress neurotoxic effects of amyloids, which we will test in Aim 2.

Public health relevance
PROJECT NARRATIVE Despite the development of effective antiretroviral therapies, HIV-associated neurocognitive disorders (HAND) remain prevalent but the underlying causes are complex and still poorly understood. We discovered that amyloid precursor protein (APP) restricts HIV-1 replication in brain-resident immune cells but in evading this restriction, HIV-1 accelerates APP processing into neurotoxic Aβ products. This proposal builds on new preliminary data that begin to reveal the underlying mechanisms of restriction by APP and the neurotoxic consequences of viral evasion strategies, and begins to explore the potential of inhibitors targeting APP processing as multifunctional therapeutics that simultaneously limit HIV-1 replication and neurotoxin production.